ZellScanner ONE

Project Summary/Abstract This request is for funds to purchase a Canopy Biosciences ZellScanner One high-multiplexing chip cytometer. There is no ZellScanner imaging platform at the University of Pittsburgh or within 100 miles. Unique as an instrument, the ZellScanner system combines the strengths of multiparameter flow cytometry (marker co-expression, quantitative, sensitive) with microscopy (positional information, tissue architecture, subcellular detail) to permit analysis of highly defined immune subsets and their spatial positioning in the native tissue microenvironment. Such high content imaging allows for deep insights into immune cell subpopulations in the context of tissue localization. The instrument will be housed within the Unified Flow Cytometry Core, a centralized core, at the University of Pittsburgh School of Medicine. The Unified Flow Core currently serves over 180 Pis and 500 individual Users. For the proposed instrument, Major Users include 13 Pis (10 NiH funded) with another 5 Pis as Minor Users. Together, these Pis have over $20 M in NiH-funded direct costs from at least 4 different institutes. A major research focus is in the broad area of immunology and allied immune diseases, with sister disciplines such as transplantation, rheumatology, vascular biology, and oncology also well represented. While the Unified Flow Cytometry Core is well-endowed with traditional (though busy) analyzers and sorters, the ZellScanner chip cytometer brings totally new breadth to our research capabilities. Our preliminary and demo work proved to us that this instrument will truly allow our investigators to break new ground in their research. The demo phase of this instrument indeed created great excitement among the Pis and hands-on Users. The new machine will be well cared for by the staff of the Unified Flow Cytometry Core, which has an extensive infrastructure and culture in place to train Users, oversee the machine and ensure that it is self-supporting. Two experienced core personnel will be responsible for the conceptual and day to day aspects of experiments on the ZellScanner unit. We will start and certify the machine each morning and troubleshoot any problems, as we will do at any time during working hours. As such, it will have a remarkable impact on the productivity of an outstanding and well-funded cohort of PHS investigators.

Public health relevance
Project Narrative This application seeks funds to place a Canopy ZellScanner One high-multiplexing chip cytometer within the Unified Flow Core at the University of Pittsburgh School of Medicine. This instrument will elevate the ongoing research of 13 Major Users as well as 5 Minor Users to a new level of technical sophistication that combines high-content cytometry with tissue imaging capabilities. The power of multiplex imaging technology to discriminate the multiple cell types in their precise tissue locations along with simultaneously-detect biomarkers and patterns of co-expression will advance the pace of research across multiple disciplines including immunology, cancer biology and infectious disease; our Users have >$20 M per year of NIH funded research that will benefit.